Novel Benzyl-Piperidine antifungal agents to treat intractable Mucorales infections

Title: Novel Benzyl-Piperidine antifungal agents to treat intractable Mucorales infections
ABSTRACT.
The fungal order Mucorales [a WHO “High Priority Group” fungal pathogen] are the causative agents
of mucormycosis, an aggressive, opportunistic mould infection that has devasting outcomes, with
an overall mortality rate of ~50-60%. Mucormycosis primarily afflicts immunosuppressed patients.
The progression of the disease is rapid. Once the infection has disseminated, it is almost always
fatal. Treatment options for mucormycosis are severely limited, as these fungi are intrinsically
resistant to contemporary antifungals, including the echinocandins and most of the azoles. The
antifungal agents in the development pipeline exhibit poor or no activity against Mucorales, making
the development of new, potent, and safe antifungals against Mucorales remains an urgent, unmet
need. To address this need, we identified a novel series of Benzyl-Piperidines (BPs) that exhibit
potent antifungal activity against pathogenic moulds. A representative BP, MBX-7591, exhibited
potent antifungal activity against representative pathogens of the Mucorales, such as Rhizopus
delemar and Mucor lusitanicus, in in vitro susceptibility assays and in a murine model of acute
invasive pulmonary mucormycosis. Based on these exciting results, we propose to develop the BP
series into a promising new generation of safe and in vivo efficacious small molecules to combat the
growing emergence of drug-resistant human fungal infections. The goal of this Phase 1 STTR
application is to chemically optimize the BP series to improve drug-like properties and antifungal
activity against Mucorales using an SAR-driven approach. In Aim 1, we will chemically optimize the
drug-like properties and antifungal activity of the BP lead series vs. Mucor species using an SAR-
driven medicinal chemistry approach. Novel analogs will be evaluated in an assay funnel and
prioritized based on in vitro potency, cytotoxicity, in vitro ADME and toxicology assays in Aim 2. SAR
data will be used in the design of new analogs in an iterative process that will result in 2-3 analogs
that will meet the criteria for Lead Compound designation. Analogs that meet the cumulative
milestones of Aims 1 and 2 will be evaluated in in vivo assays for tolerability, pharmacokinetics, and
efficacy in a murine model of invasive pulmonary mucormycosis in Aim 3. An analog that meets the
cumulative milestone criteria for Aims 1-3 will be designated as a Lead Compound that will be
optimized further in a follow-on Phase 2 project, resulting in a Preclinical Candidate that is ready for
IND-enabling preclinical development. Taken together, the proposed studies will further develop an
exciting series of novel small molecules with the potential to meet an unmet medical need posed by
clinically challenging, pathogenic moulds.

Public health relevance
PROJECT NARRATIVE. Invasive fungal infections in immune compromised patients, such as those undergoing chemotherapy or high dose corticosteroid treatments, are a major impediment to human health. Infections by moulds are particularly problematic and often resistant to contemporary antifungal therapy. This proposal will further develop a novel small molecule with potent antifungal activity against human pathogenic moulds.